Expansion of an established breeding SPF Program at CPRC

SUMMARY
The rhesus macaque (Macaca mulatta) is the most commonly used nonhuman primate model in biomedical
research. Nonhuman primate models are of growing importance for HIV/AIDS-related research to develop
vaccines, therapeutic interventions a potential cure and other approaches. However, it is well-known that the
demand by the research community of rhesus macaques, remains greater than their availability. The CPRC have
been critical for maintaining the momentum of NIH-supported. Over the last three years (2020-2023), 700
animals (app 230/year) have been available from this program supporting $57,866,376 of NIH-high priority
HIV/AIDS-research, mainly R01, P01, U01- funded academic investigators and NIAID-DAIDS-SVEU programs.
This NOFO presents an opportune moment to bolster CPRC's SPF program, aiming to add at least 350
new animals in 5 years and 1,000 in 10 years, significantly enhancing the Center's resources for cutting-
edge research on NIH-funded HIV/AIDS.